Baccalaureate Bridge to the Biomedical Sciences Program (ACCESS)

UCSC ACCESS PROPOSAL PROJECT SUMMARY/ABSTRACT
Baccalaureate Bridge to the Biomedical Sciences (ACCESS)
R25-GM051765
The University of California at Santa Cruz (UCSC) proposes to continue our training grant (which we
have titled “Baccalaureate Bridge to the Biomedical Sciences (ACCESS)”. This five-year grant renewal is for
2019-20 to 2023-24 AYs. It renews a consortium involving biomedical scientists at UCSC, the baccalaureate
institution, engaged in a partnership with four Associate Degree (A.A.) institutions. Joining the research
faculty from two different Science Divisions at UCSC are the AA partners from chemistry and biology at
Cabrillo College (CC), Hartnell College (HC), Monterey Peninsula College (MPC), and Gavilan College (GC).
The program Aims are: (1) To improve the success and confidence of underrepresented community
college students through community college-based activities including Supplemental Instruction sessions
and mentoring in introductory chemistry and biology courses. (2) To motivate first year community college
science students through the Mini-Research Camp presented as a collaborative effort between Community
College and UCSC faculty and staff. (3) To provide underrepresented students with a foundation of
fundamental skills and experiences in an 8-week Summer Research Institute held at UCSC. (4) To link
academic course work with pathways leading to careers in the biotechnical sciences. This will motivate
ACCESS students to consider curriculum and degree choices relevant to becoming a biotech science
professional vs. the obvious health professional career tracks known to most beginning college students.
(5) To engage matriculated ACCESS students at UCSC as peer mentors and use existing UCSC STEM
programs to enable their participation in academic year-based undergraduate biomedical research.

Public health relevance
UCSC ACCESS PROPOSAL PROJECT NARRATIVE Baccalaureate Bridge to the Biomedical Sciences (ACCESS) R25-GM051765 The elements guiding this project will address a national goal which is to remedy the under- representation of minority and disadvantaged groups and individuals with disabilities in science. The mechanisms of this grant is to have UC Santa Cruz research/teaching faculty working alongside community college instructors as mentors for undergraduates who are still formulating their career choices and research directions. The plan for implementation includes improving success/confidence of underrepresented community college students, motivating students through the Mini-Research Camp presented as a collaborative effort between Community College and UCSC faculty and staff, providing research experiences via the 8-week Summer Research Institute, linking academic course work with pathways leading to careers in the biotechnical sciences and engaging ACCESS students at UCSC as peer mentors to enable their participation in academic year-based undergraduate biomedical research.